Cellular mechanisms of perivascular fibroblast development and dependence on PDGF signaling

PROJECT SUMMARY
Perivascular spaces (PVSs) are fluid-filled spaces surrounding vessels of the central nervous system,
are thought to have important roles in maintenance of brain health, and are a unique niche for a variety of
perivascular cell types. A cell type of particular interest is perivascular fibroblasts (PVFs) which are poorly
characterized, and their functions are largely unknown. PVFs are known to reside on the outside the vascular
smooth muscle layer of medium-to large-diameter vessels in the adult mouse central nervous system, and are
primarily identified by expression of Collagen-1 and Platelet-derived growth factor receptor (PDGFR)a and
PDGFRb. However, nearly nothing is known about the developmental origins, or the cellular and molecular
mechanisms important for PVF development. Preliminary data suggests PVFs emerge from a population of cells
in the meninges and gradually populate brain PVSs during postnatal development, but this has not yet been
investigated further. These gap in knowledge is a major barrier to developing novel tools to investigate the role
of PVFs in brain homeostasis and disease. The objective of this proposal is to investigate the developmental
origins, cellular dynamics, and molecular signaling mechanisms involved in PVF development. In Aim 1, I will
use a combination of transgenic mouse lines that label PVFs, optical tissue clearing, ex vivo imaging, and a
multi-color lineage tracing reporter to investigate the cellular origins and dynamics of developing PVFs. In Aim
2, I will use intracisternal cerebrospinal fluid tracer assays to determine the relationship between the timing of
PVF development and PVS function. Finally, in Aim 3 I will investigate PDGF signaling as a potential mechanism
controlling PVF development. Together, this project will be the first to fully characterize how PVF development
occurs and whether or not PDGF signaling is involved.

Public health relevance
PROJECT NARRATIVE Perivascular fibroblasts (PVFs) reside within perivascular spaces of the adult murine brain, are identified by expression of Collagen-1 and Platelet-derived growth factor receptors (PDGFR)a and PDGFRb, and have almost exclusively been studied in the context of stroke and injury. However, almost nothing is known about PVF developmental origins and timing, or the cellular and molecular mechanisms involved in their development. This will be the focus of my investigations, and the results from this work will allow for novel tools and methods for studying the homeostatic and disease-related functions of PVFs.